Neuronal control of body weight and size by the Gbeta5-R7 signaling complex

Abstract Obesity is a major co-morbidity factor in diabetes, cancer, cardiovascular, neurological and other diseases. One group of genes recently linked to obesity in humans are genes encoding the R7 family of regulator of G protein signaling proteins (RGS6, 7, 9 and 11) and Gnb5, which encodes the G protein beta subunit Gβ5. Gβ5 and R7 proteins form obligatory dimers, so that the Gnb5 knockout causes complete degradation of the entire Gβ5-R7 complex. This proposal studies how a deficiency in the Gnb5 and R7 genes can lead to obesity; the ultimate goal is to discover effective treatments of disorders associated with neuroendocrine pathways regulated by these genes. The proposed research plan builds upon earlier discoveries that together constitute a strong premise for this study. Ablation of one Gnb5 allele leads to obesity and metabolic syndrome in mice; this finding was later confirmed by human genetics. Subsequent mechanistic investigations in this lab identified a novel role for the Gβ5-R7 complex in pancreatic beta cells where Gβ5-R7 strongly promoted insulin secretion. Brain is the main organ regulating body weight, and the expression level of Gβ5-R7 is much higher than in the pancreas or any other peripheral tissues. These considerations lead to the hypothesis that Gβ5-RGS7 regulates body weight via its function in the CNS, where as in the insulin-secreting beta cells, Gβ5-R7 can regulate hormone and/or neurotransmitter secretion by neurons. In support of this hypothesis, recent studies in the lab demonstrated that local knockout of Gnb5 in the hypothalamus using LoxP/Cre technology caused a dramatic increase of body weight and adiposity in adult mice. The proposed research will develop this discovery. Specific Aim 1 will analyze the effects of Gnb5 ablation in specific hypothalamic nuclei and types of neurons on body weight and levels of various hormones. Overexpression of Gnb5 using viral-mediated gene transfer will be performed to rescue obesity. Aim 2 will determine which hormones and signaling proteins (i.e., GPCRs) are co-expressed with Gnb5 in hypothalamic neurons. Tissue and acutely cultured neurons will be examined for secretion of specific hormones and signaling. Specific Aim 3 will study molecular events affected by Gβ5-R7 via its knockout (CRISPR/Cas9), knockdown and overexpression in cell lines that endogenously express M3R and Gβ5-R7. Experiments will focus on signaling, structure-function analysis of Gβ5-R7 and signal-stimulated secretion utilizing pharmacological agents and biochemical and biophysical assays. Through unraveling a novel mechanism that regulates neuronal functions, this project may have a strong impact on understanding etiology of obesity and other neuroendocrine disorders.

Public health relevance
Project Narrative Many pathologic conditions are associated with genetic or acquired abnormalities in the levels of hormones secreted by the central nervous system. This project studies Gbeta5-R7, a protein complex highly expressed in the brain, and the new finding is it is responsible for maintaining normal body weight in mice. Mutations in the human genes that encode Gb5-R7 are genetically linked in with obesity, and this research will develop a new avenue for understanding, diagnostics and treatment of metabolic disorders.